Contribution of Endothelial Planar Cell Polarity pathways in Blood Flow Direction Sensing

PROJECT SUMMARY
Vascular function and development are largely mediated by vascular endothelial cells (VECs)
that line the inner wall of blood vessels. Fluid shear stress (FSS) generated by blood flow is a
major determinant of their function and phenotype with major roles in development, physiology,
and disease. VECs in healthy regions of arteries are under unidirectional laminar flow, where
they align in the direction of flow and activate anti-inflammatory pathways which confers
resistance to atherosclerosis. By contrast, VECs in curved or branched regions of arteries
develop disturbances in flow patterns. These disturbed flow patterns fail to align VECs and
activate inflammatory pathways, which correlates with susceptibility to form atherosclerotic
plaque. FSS direction with respect to cell alignment also regulates inflammatory signaling
outputs, which suggests cell polarity and flow direction sensing is important for the differential
atheroprotective and atheroprone responses. Thus, how VECs sense and respond to flow
direction is an important basic science question pertinent to human health, but the mechanism
is unclear. A junctional flow-dependent complex comprising of VE-Cahderin, PECAM1, and
VEGF is critical for integrating endothelial cell flow responses. Our lab recently discovered that
the polarity adaptor protein, LGN, which binds directly to VE-Cahderin is important for proper
endothelial cell alignment. Since LGN directly interacts with a flow dependent mechanosensitive
complex and has an established role regulating cytoskeletal dynamics, I hypothesize LGN is
important for flow direction sensing. I plan to address this hypothesis using the following specific
aims: Aim 1: Characterize the mechanism by generating mutations in LGN’s functional domains
to determine which sites are important for mediating endothelial cell flow dependent signaling. I
will similarly examine the effects of known LGN interactors if they are shown to be crucial for
flow mediated signaling. Aim 2: Examine the role of cell polarity in flow signaling. I will do this
first by tracking the intracellular localization of LGN in response to flow and use patterned
substrates to separately constrain cell and cytoskeletal polarity to determine which of these
variables is important for LGN polarity and inflammatory vs. anti-inflammatory signaling. Aim 3:
Determine the role of LGN in vivo by analyzing mice with endothelial deletion of LGN which will
address the role of LGN in VEC alignment, inflammation, and resulting atherosclerosis in vivo.
Together, these aims will reveal new mechanisms for endothelial flow sensing, vascular
inflammation, and atherosclerotic disease.

Public health relevance
NARRATIVE Disrupted endothelial cell flow sensing and flow profiles have been linked vascular diseases such as atherosclerosis. Whether endothelial cell’s signals are athero-protective or athero-prone depends on the direction of blood flow with respect to cell morphology. The mechanism for how endothelial cells sense flow direction is largely unknown, and this project aims to elucidate a potential mechanism.